INVESTIGATION OF CLINICAL AND HORMONAL EFFECTS OF ORAL GHRP

GHRP will be administered orally to 10 normal adult men to determine its safety, clinical effects, if it will stimulate GH secretion and the dose response relationship and time course.